Deciphering the role of long noncoding RNA Pvt1 in preclinical models of ADPKD

ABSTRACT
Autosomal dominant polycystic kidney disease (ADPKD) is a very common, monogenetic kidney
disorder, affecting approximately 300,000 Americans1, 2. ADPKD primarily results from mutations
in PKD1 and PKD23. The pathophysiology of ADPKD is incompletely understood and treatment
options are limited. Long noncoding RNAs (lncRNA) – defined by a length >200 nucleotides and
absence of a long open reading frame – are a class of non-protein-coding RNAs implicated in a
range of disease4, 5. They have emerged as an exciting new drug target category for many
common conditions6. However, the role of lncRNAs in ADPKD has been understudied. In a recent
study, we found that the lncRNA Pvt1 is highly upregulated in mouse and humans with ADPKD7.
Pvt1 is a known oncogenic lncRNA that is overexpressed in many cancers and regulates Myc,
other transcription factors, and multiple miRNAs, some of which have major functions in ADPKD8-
11. The role of Pvt1 in ADPKD is not known. We developed a Pkd1-mutant mouse metanephric
organ culture (MOC) as a cost-effective model to manipulate gene expression and identify targets
that modulate cystogenesis7. We discovered that self-complementary adeno-associated virus
(scAAV), serotype DJ, is highly effective in transducing epithelial cells of the mouse MOC. We
used scAAV/DJ shRNA to knockdown Pvt1 in Pkd1-null MOCs. We noted that knockdown of Pvt1
markedly reduced cyst index and downregulated c-MYC protein levels in Pkd1-null kidneys.
Based on these promising findings, we propose the following aims: 1) test whether ablation of
Pvt1 ameliorates cystogenesis in mouse ADPKD, and 2) determine the contribution of PVT1 in
human ADPKD by silencing PVT1 in kidney organoids derived from PKD1-mutant hESCs. If
successful, results from this study will confirm pathogenic upregulation of PVT1 in-vivo ADPKD,
which will form the basis of R01 application.

Public health relevance
PROJECT NARRATIVE Preventing or mitigating cystogenesis is crucial to the long-term survival and quality of life of patients with polycystic kidney disease (PKD). Our approach focuses on targeting a single noncoding RNA to manipulate multiple genes, proteins, and pathways. Should we succeed, it would open the door for exploring the therapeutic potential of inhibiting PVT1 and reducing c- MYC levels to ameliorate cystogenesis in ADPKD.